Roles of the glycogen synthase kinase 3 alpha isoform in Alzheimers disease pathophysiology

Project Summary/Abstract
Alzheimer’s disease (AD) is an aging-related multifactorial neurodegenerative disorder characterized by
cognitive impairment and synaptic failure. Elucidation of the molecular signaling pathways that go awry in AD
could provide insights into etiology and potential therapeutic strategies for this devastating neurodegenerative
disease. Mounting evidence has linked abnormal over-activity of glycogen synthase kinase 3 (GSK3) to multiple
aspects of AD pathophysiology. Meanwhile, the development of therapies based on GSK3 inhibition has been
hindered by the lack of understanding of isoform-specific neuronal effects, particularly for GSK3α, which has
been largely overlooked compared to GSK3β. Challenges in developing isoform-selective inhibitors for GSK3
present another layer of difficulties since inhibition of both α and β isoforms could result in significant toxicity.
This project is aimed to investigate the isoform-specific roles of GSK3 in AD pathogenesis. We have selectively
suppressed GSK3α or β isoform in the brain of AD model mice using genetic approaches. Moreover, we will test
the first-in-class isoform-selective antagonists of GSK3 in AD models. Based on previous work and preliminary
studies, the central hypothesis to be tested is that disruption of GSK3 isoforms, particularly GSK3α, represents
a key molecular signaling mechanism underpinning AD-associated cognitive impairment. There are three
specific aims. Aim 1 seeks to elucidate roles of GSK3α isoform in AD-associated synaptic plasticity impairments.
Aim 2 is to determine the effects of GSK3 isoform-specific inhibition on cognitive impairments in AD model mice.
Aim 3 is to identify molecular mechanisms associated with GSK3 isoform-specific roles in AD. The project
includes in-depth analyses using multiple experimental approaches, including synaptic electrophysiology,
pharmacology, imaging, mouse genetics, proteomics/phosphoproteomics, and behavioral tests. Data derived
from the proposed studies could uncover previously unrecognized isoform-specific roles of GSK3 signaling
dysregulation in AD etiology. The multidisciplinary approach shall enable us to identify detailed mechanisms
associated with aberrant GSK3 isoform signaling in AD pathogenesis, thus providing insights into effective
therapeutic targets and diagnostic biomarkers for AD and other aging-related cognitive syndromes.

Public health relevance
Project Narrative Elucidation of the basic causes underlying cognitive impairments in Alzheimer’s disease (AD) and other neuronal diseases would facilitate the development of effective therapeutic and diagnostic strategies. This project will help determine the roles of the signaling pathway associated with the glycogen synthase kinase 3 (GSK3) isoforms in AD pathogenesis. The results of this work could help understand the etiology and inform the future identification of novel therapeutic targets for AD and related dementia syndromes.